Biochemical and Chemical Training for Cancer Research

This renewal application seeks support for the training of predoctoral students and postdoctoral
fellows in biochemical, chemical, and structural approaches for cancer research. The training
program integrates contemporary cancer biology (e.g., oncogenes and tumor suppressors,
signal transduction, oncogenic transcription factors, DNA modifications, cell cycle control,
genomic surveillance) with the allied fields of chemical and structural biology (high resolution
analysis of proteins and DNA, carcinogenic DNA adducts, and chemotherapeutic drug design).
Over the past 30 years, this Training Program has an outstanding training record and seeks to
continue this multidisciplinary training program that is composed of 26 preceptors from seven
academic departments and 2 programs representing both the Vanderbilt University School of
Medicine and the College of Arts and Sciences. The training program is conducted within a
vibrant academic environment and is supported by close interactions with the Vanderbilt-Ingram
NCI-designated Comprehensive Cancer Center, the Vanderbilt Institute of Chemical Biology,
and the Vanderbilt Center for Structural Biology, all of which offer resources for trainees and
preceptors. In addition to departmental and preceptor-specific laboratory instruction, each
trainee receives cancer-related training in the form of two courses focused on cancer biology
and experimental cancer research. An Interdisciplinary Graduate Program (IGP), the Chemical
and Physical Biology Program (CPB), and an independent graduate program in Chemistry all
academically support predoctoral trainees. This renewal applications highlights several new
enhancements to our training program including a new Precision Cancer Medicine course that
provides an immersive clinical experience. We are also launching an 8-week workshop in
bioinformics for large datasets that is led by our senior trainees who will mentor our junior
trainees in these genomic and proteomic methods. We have an active mentoring program that
includes former student trainees, postdoctoral mentors, and faculty mentors, which ensures the
continued development of academic skills for cancer research and career development.
Significant institutional investment in training programs, core facilities, state-of-the-art
laboratories and equipment that provide technology resources applicable to cancer biology and
molecular structures also enhance trainee development. This integrated training in biochemistry,
chemistry, structural biology, and cancer biology is critical to the molecular understanding of
cancer and the development of new approaches to molecularly targeted therapeutics.

Public health relevance
This renewal application seeks support for the training of predoctoral students and postdoctoral fellows in biochemical, chemical, and structural approaches for cancer research. Integrated training in biochemistry, chemistry, structural biology, and cancer biology is critical to the molecular understanding of cancer and the development of new approaches to molecularly targeted therapeutics.